TOLERABILITY OF BRL 49653C ADMINISTERED TO PATIENTS WITH NIDDM

The hypoglycemic activity of BRL 49653C has been demonstrated in patients with niddm compared to placebo. This trial is designed to determine the effect of BRL 49653C alone V combination with metformin V metformin alone.